University of Washington Arboviral Research Network (UWARN)

Abstract: University of Washington Arboviral Research Network (UWARN)
The University of Washington Arboviral Research Network (UWARN) will address emerging and re-emerging
infectious diseases by carrying out research on arboviruses that include current high burden pathogens including
dengue, chikungunya, and Zika viruses. Arboviruses also include emerging and re-emerging viruses such as
Mayaro, Una, Usutu, Japanese encephalitis, yellow fever, Crimean-Congo hemorrhagic fever, and Oropouche
viruses. UWARN will leverage the UW Metacenter for Pandemic Disease Preparedness and strong research
laboratory partners in Brazil, Senegal, South Africa, Pakistan and Taiwan as well as the UW Department of
Global Health global reach in capacity building. The UWARN international Collaborating Partners have
institution-based and population-based cohorts in place to carry out the planned research and monitor for new
virus emergence. The proposed UWARN research will create new human viral-neutralizing monoclonal
antibodies (Hu-nMabs) that can be used as therapeutics or diagnostics. UWARN research will also create new
diagnostics, created ab initio by the Institute for Protein Design, as artificial proteins that release light when
antibodies to virus are present in body fluids. Finally, UWARN research will generate an understanding of how
viruses manipulate the human innate immune system, and this information will be used to design biomarkers to
predict severe disease as well as to suggest host-directed therapies that could lead to better outcomes after
arboviral infection. The proposed technologies are generic and could be rapidly adapted to any future emerging
arbovirus threat. UWARN collaborators span virology, bacteriology, mycology, and parasitic infections, such that
UWARN can respond to diverse emerging infectious diseases threats. UWARN international laboratories have
advanced capabilities including biorepositories with generator-power backed-up -80C freezers, next-generation
sequencing (NGS) capabilities, fluorescence cell sorting, and BSL-3 containment facilities. UWARN cohorts have
biobanked samples taken from individuals during acute febrile illnesses, with known and unknown arboviral
diseases, and partnership sites are poised for prospective collection of population and facility–based samples.
UWARN labs will use metagenomic NGS to detect novel viral emergence in affiliated cohorts. UWARN Partners
have collaborating entomologists and veterinarians to sample arthropod vectors and animal reservoirs as
needed. Additional innovative capacity included the Brazil UWARN partner’s mobile van with on board NGS
capability for real-time, on-site viral sequencing and sampling to viral identification in less than 18 hrs. A second
partner, IRESSEF in Senegal, plans to set up a similar mobile vehicle for viral sampling and sequencing in
Senegal and the Brazil group will collaborate with IRESSEF on technology transfer and best practices. UWARN
partners will serve as a resource to other Emerging Infectious Diseases Research Centers (EIDRC) providing
expertise in monoclonal antibodies, protein design, and host directed therapies.

Public health relevance
NARRATIVE: University of Washington Arboviral Research Network (UWARN) The University of Washington Arboviral Research Network (UWARN) will address emerging and re-emerging infectious diseases by carrying out research on arboviruses, viruses transmitted by arthropods to humans, with collaborating partner research laboratories in Brazil, Pakistan, Senegal, South Africa and Taiwan. The research will develop innovative new diagnostic reagents, namely human viral-neutralizing antibodies and designed proteins that release light when antibodies to virus are present in blood. UWARN research will also improve understanding of how viruses manipulate the human immune system, facilitating development of better biomarkers to predict severe disease as well as host-directed therapies that could improve outcomes of viral infection.